The role of arteriogenesis on structural and functional neurovascular recovery after cerebral stroke

PROJECT SUMMARY/ABSTRACT Cerebral stroke leads to long-term disability, yet post-stroke treatment remains primarily limited to rehabilitation. The partial functional recovery that does occur is due in part to neurovascular plasticity of the brain region adjacent to stroke damage—the peri-stroke penumbra. However, attempts to manipulate the neurovasculature post-stroke by promoting angiogenesis—sprouting of new capillary vessels—have not been successful, in part because angiogenesis can lead to tortuous, leaky vessels that do not increase blood flow. Alternatively, arteriogenesis—the generation of large-bore vessels in response to shear stress—could play an important role in post-stroke recovery and represent a novel therapeutic target. However, the lack of tools to specifically manipulate arteriogenesis has hampered efforts to test this hypothesis. We identified Dach1, an endothelial transcription factor, as a specific driver of arteriogenesis. Here, we will use new mouse models that allow us to bi-directionally control Dach1 levels in endothelial cells, to determine to what extent arteriogenesis is involved in post-stroke recovery of brain functions. Specifically, we will examine the links between arteriogenesis and post- stroke recovery of the vascular network (Aim 1), neurovascular coupling (Aim 2), and behavior (Aim 3). Our long-term goal is to understand the mechanisms of adaptive post-stroke neurovascular plasticity to develop new treatments and improve brain health. Funding of this proposal will enable an unbiased study of the brain following stroke with unprecedented temporal and spatial resolution in freely behaving animals, identify the specific role of arteriogenesis in post-stroke recovery, and may unveil new therapeutic targets that enhance the therapeutic window of post-stroke rehabilitation, which is a key limiting factor in treating stroke patients. This diversity supplement grant will significantly enhance the research potential of Ms. Zanib Naeem, and make her competitive for top-tier biomedical science PhD and MD/PhD programs. Ms. Naeem will be involved in a team project that focuses on the neurobiology of stroke, and gain expertise in mouse behavioral assays, in vivo electrophysiology and imaging, and data analysis. She will also participate in the Post-Bac Program for Equity and Learning (PROPEL) curriculum activities, on which the PI (Jeanne Paz) serves as a mentor. Through the Propel program, Ms. Naeem will both participate in biomedical seminars and have access to career development opportunities, such as grant writing workshops and mock interviews.

Public health relevance
NARRATIVE Cerebral stroke is a common cause of long-term disability, yet current post-stroke treatments have a very short therapeutic window, impairing post-stroke rehabilitation leading to incomplete recovery. In theory, vascular remodeling should improve blood flow and enable structural and functional recovery from stroke, but previous attempts to accomplish this by increasing angiogenesis (i.e. growth of new capillary vessels) have been unsuccessful. In this supplement application, the goal is for Ms. Zanib Naeem to use mouse behavioral assays and in vivo electrophysiology and imaging, to determine the effect of inducing arteriogenesis on post-stroke recovery.